Neuroplasticity in chemosensory-mediated social behaviors

Summary
During development and throughout adulthood, humans display strong neuroplasticity, the capacity of
adaptive changes of neurons and neural circuits in response to social environments. Plasticity in chemosensory
system is essential for learning and memory, social communication and quality of life. Loss of olfactory sensing
(anosmia) leads to social isolation, neurological diseases, such as schizophrenia, Alzheimer’s disease (AD) and
Parkinson’s disease (PD), and social disorders such as autism. However, the role of neuroplasticity in olfactory-
mediated social behaviors is unclear and understudied. We and other labs have developed genetic tools in ants,
thereby providing a novel model to study olfactory neuroplasticity in social organisms, as (a) ants are highly social
and display complex social behavior; (b) ants display striking neuroplasticity during development and throughout
adulthood; (c) neuronal activity is likely required for proper development of olfactory neurons in ants, which is
reminiscent of activity-dependent neuronal survival in mammals.
The Drosophila genome contains 60 odorant receptor (Or) genes, while 300-500 Or genes have been
identified in several ant genomes. In the ant Harpegnathos saltator, mutation in the gene odorant receptor co-
receptor (orco), which disrupts the function of all ORs, significantly impacts ant olfaction, and mutant animals
display a wide range of abnormal social behaviors. Surprisingly, and unlike other insects, such as Drosophila, this
loss of OR functionality during development dramatically reduces the number of odorant receptor neurons (ORNs)
and antennal lobe (AL) glomeruli where ORNs project. Further transcriptome analysis suggests that there are two
types of ORNs: activity-dependent and activity-independent ORNs. We will use these features in the orco-/- ants
and perform a series of molecular and cellular experiments to determine (a) the role of neuronal activity and
receptor trafficking in olfactory neuronal survival, and (b) the role of gustatory and ionotropic receptors in neural
development.

Public health relevance
Narrative Neuroplasticity is essential for chemosensory-mediated behavior in social animals. Ants are highly social and provide a new platform to study chemosensory neural development and complex social behavior. We have developed genetic tools in ants to study how neural development and plasticity are modulated for their social communication.